Atherosclerosis Risk in Communities - Retinal component

We investigated the incidence and prevalence of retinopathy in a sample of 981 middle-aged ARIC study participants who were selected to participate in the third and fourth ARIC study examinations and who had retinal photographs of the same eye taken at both study visits. The prevalence of retinopathy was 7.7%, with 3.8% of people developing signs of retinopathy in the three year interval between exams. Although the rate of retinopathy was found to be higher among diabetics (40 of 147), a comparable number of cases occurred in non-diabetic individuals (36 of 834). Factors found to increase risk of retinopathy include higher levels of blood pressure, fasting serum glucose, total cholesterol, and plasma fibrinogen. We examined 10 year changed in retinal microvascular lesions in a sample of ARIC participants and found that, over a decade, new retinal vessels appeared and a significant proportion disappeared, suggesting considerable remodeling in the retinal microvasculature. For more information about the study, including the full list of investigators and participating institutions and resulting publications, see http://www.cscc.unc.edu/carmri/ Data analysis of ocular phenotypes in conjunction with genotype data is on-going. Findings from this study are being merged with those from other aging and cardiovascular cohorts participating in the CHARGE Consortium to allow for increased power to detect genetic signals of disease. See PLOS Genetics Oct 2010 e1001184. Building on findings reported in the PLOS Genetics paper, sequencing of a sample of ARIC and CHS participants is on-going with expected completion in 2011 (as part of a larger effort under the direction of Dr. Eric Boerwinkle).